Leveraging Integrative Modeling and AI-Based Tools to Develop Safer Opioids

PROJECT SUMMARY
The misuse of opioid painkillers targeting the -opioid receptor (MOR) continues to result in record numbers of
overdose deaths, underscoring the pressing need to identify safer analgesics, as well as effective therapies for
opioid use disorder (OUD). Although
efficacy
with
(e.g.,
preferable drugs that can sufficiently engage pain pathways to provide therapeutic
relief while leading to lower side effects through reduced engagement of their mediating circuits. Understanding
not free from liabilities, several MOR small-molecules that exhibit low-
agonism for relevant G protein subtypes (e.g., buprenorphine and oliceridine) are powerful analgesics
i mproved safety profiles compared to other opioids used clinically (e.g., morphine) or commonly abused
fentanyl). This supports the emerging paradigm in the field that low-efficacy MOR agonists may be
candidates for developing
howlow-efficacy agonists activate MOR-mediated G protein pathways differently from high-efficacy opioid drugs
is essential for informing the design of safer opioid therapeutics. Achieving this understanding requires an
unprecedented level of spatial resolution of both the conformational dynamics and kinetics of ligand-specific
MOR-Gi1 coupling and activation, which cannot currently be obtained by a single technique. Instead, it
necessitates the integration of data from both experimental and computational sources.
Our team is uniquely positioned to tackle this challenge using an innovative Bayesian inference framework to
integrate comprehensive conformational ensembles from physics-based enhanced molecular dynamics
simulations with state-of-the-art single-molecule imaging data collected at unprecedented time resolution both
inpurified protein preparations and in living cellsby long-standing experimental collaborators. This integration
will yield more accurate atomistic information regarding ligand-specific MOR-G protein conformations and their
kinetic relationships, from which we can derive accurate predictions about the unique attributes of low-efficacy
opioids. Experimental validation of these predictions will not only help us achieve the overarching goal of
elucidating the mechanistic basis of opioid efficacy but also bolster the
architectures and inform optimal
training of
guidelines for developing novel chemotypes in the pursuit of safer opioid
artificial intelligence
medications.

Public health relevance
PROJECT NARRATIVE The research outlined in this application aims to obtain mechanistic information from integrated computational and single-molecule imaging data that can be probed experimentally to aid in understanding opioid modulation how low-efficacy  receptor (MOR) agonists with demonstrated improved safety profiles differ from lethal opioid drugs in their of ligand-MOR-transducer complexes at the molecular, dynamic, and kinetic levels - . This fundamental knowledge is critical for discovering safer opioid drugs.